LONG TERM EVALUATION OF ZONISAMIDE IN THERAPY OF SEIZURE IN REFRACTORY PATIENTS

Zonisamide, a new AED, is being investigated to determine the efficacy & safety of the agent in patients 12 years and up with a diagnosis of epilepsy. Subjects will have failed traditional therapy.